DNA CAPILLARY ELECTROPHORESIS PROTOCOLS AND PROCESSES

Using fast video microscopy and electrophoresis we will investigate of the mechanism of pulsed field electrophoresis of DNA in polymer solutions. We will test the hypothesis that pulsed field electrophoresis operates to reduce the range of entanglement times of DNA and the entangling polymer. Proposed synchronization mechanisms will be tested by cross-correlation of individual molecule velocities and extensions, and by fluorescence anisotropy imaging of orientable labeled dextrans. Similar studies will be performed to elucidate the electrophoretic dynamics of sc-plasmid DNA and topoisomerases will be used to generate individual topoisomers for detailed study of band broadening. Three-dimensional video microscopy based on fast serial sectioning will be used to elucidate the migration dynamics in detail. Size exclusion electrochromatographic separation techniques will be developed for lightly charged or uncharged plasmid complexes. Prior electrophoretic separation may be used for plasmids and ds-DNA. Applications and mechanisms of electrophoresis in ultraconcentrated polyacrylamide solution will be investigated. Pulsed field electrophoresis will be used to improve the resolution in the 100 kbp - 1 Mbp range and video microscopy to investigate the unusual dynamics in ultraconcentrated polyacrylamide and related media. Additionally, analyte velocity modulation will be explored as a fluorescence background rejection technique for protein separations in plastic microchips. The electrophoresis driving voltage will be modulated at low frequency to generate a modulation component on analyte fluorescence. The concept will be tested on model protein separations, such as the serum proteins or commercial size standards.